Research Capacity Core

The Research Capacity Core (RCC) continues to build and enhance the biomedical research
infrastructure that primarily supports the activities of the CTRHD RCMI (U54). The RCC will
support 3 full projects, pilot projects, additional (non-RCMI) institutional seed grants and multiple
Morehouse School of Medicine (MSM) NIH-funded projects. The RCC will leverage resources
supported for by other NIH-funded centers and further enhance our resources in both basic
biomedical and behavioral sciences; and lay the groundwork for MSM faculty to conduct
population and health services research that utilize the Multidisciplinary Translation Team (MDTT)
approach to community engagement and health justice. The MSM RCMI RCC will continue to
maximize its role in assuring the highest quality and productivity across all research projects within
the CTRHD while maintaining support for other investigators at MSM. These goals will be
achieved through the proposed three specific aims: SA1: Restructure and enhance the RCC to
support basic biomedical and behavioral health disparities research through innovative sub-cores.
SA2: Support future pilot projects focused on interdisciplinary basic biomedical, behavioral and
population/health services research. The RCC will also support and complement Community
Engagement Core (CEC) activities, other health disparities research projects at MSM and
complement existing resources. SA3: Support and sustain the RCC sub-cores through a
structured synergetic daily management plan that includes usage (cost recovery), governance
and communication with other research partners (e.g., universities, research organizations and
industry).